CHELATION THERAPY FOR IRON OVERLOAD USING PYRIDOXAL ISONICOTINOYL HYDRAZONE

To determine if oral chelation therapy with PIH is safe and effective for patients with iron overload providing an alternative to daily parenteral infusion therapy.